Functional MRI of Aging: Biophysical Characterization

DESCRIPTION (provided by applicant): In the recent years, a number of studies using functional MRI (fMRI) have shown substantial differences between the activation pattern of older subjects (> 50 years of age) and younger subjects (21-40 years) while performing a number of different sensorimotor and cognitive tasks. It has been concluded that the contrast observed is due to differences in neuronal activity in the older subjects. However, early hypothesis that normal aging involves widespread loss of neurons have been revised in light of accumulating evidence that in most regions of the brain, the number of neurons is stable throughout adulthood and senescence. In addition to direct effects on neuronal function, factors contributing to cerebrovascular reactivity is known to be altered in older people that could give rise to altered hemodynamic responses. Since the signal observed using fMRI could be modulated both by hemodynamics and oxygenation changes resulting from neuronal changes, these two factors must be separated to gain a better understanding about age related changes in the activation pattern obtained using fMRI. The present project proposed intends to combine basic science, engineering, and computational issues to specifically elucidate mechanisms (neuronal vs vascular) that results in older subjects having altered brain activation in comparison to young subjects. Results obtained from the noninvasive technique (fMRI) would provide ways to measure a number of relevant physiological factors and characterize them biophysically to understand human brain function with aging. Methods and techniques developed can also be used to study between two or more different groups.

Public health relevance
PUBLIC HEALTH RELEVANCE: The present project will help determine biophysical aspects of aging using non-invasive functional Magnetic Resonance Imaging (fMRI). As longitudinal studies are very important to follow individuals through different stages of their life span, fMRI techniques would become crucial in obtaining valuable biomarkers in studies of aging. FMRI presents many caveats in determining the actual physiological indicators that influence signal response in young and old subjects. This project is designed to address certain caveats by effectively testing and quantifying the neural and hemodynamic components that may modulate signal response in young and old subjects. This study will significantly gain information regarding the underlying nature and necessary corrections in fMRI signals. Such a correction is necessary to accurately determine the progression and determinants of change across all segments of the life span that affect cognitive effects and brain function. Project Narrative: The present project will help determine biophysical aspects of aging using non-invasive functional Magnetic Resonance Imaging (fMRI). As longitudinal studies are very important to follow individuals through different stages of their life span, fMRI techniques would become crucial in obtaining valuable biomarkers in studies of aging. FMRI presents many caveats in determining the actual physiological indicators that influence signal response in young and old subjects. This project is designed to address certain caveats by effectively testing and quantifying the neural and hemodynamic components that may modulate signal response in young and old subjects. This study will significantly gain information regarding the underlying nature and necessary corrections in fMRI signals. Such a correction is necessary to accurately determine the progression and determinants of change across all segments of the life span that affect cognitive effects and brain function. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS: Advances in MRI technology have permitted the measurement of local hemodynamic changes, that is, changes in cerebral blood volume (Mandeville et al., 1998; Zaharchuk et al., 1999), cerebral blood flow (Barbier et al., 2001; Kastrup et al., 1998), and tissue oxygenation (Doung et al., 2001; Kastrup et al., 1999; Turner et al., 1991) within cortical areas of the brain in response to physiological perturbation. One source of such perturbation is evoked neural activity that leads to vasodilation and an increase in blood flow (Armstrong et al., 1992; Cholet et al., 1997; Yang et al., 1996), resulting in net changes in local concentrations of oxy- and deoxyhemoglobin (Ogawa et al., 1990; Ogawa et al., 1992; Stehling et al., 1993) that can be observed as changes in MRI signal intensity. Thus, the hemodynamic response that follows neural activity is the basis for blood-oxygen-level-dependent (BOLD) contrast. For these reasons, changes in hemodynamic activity, detected by MRI, are often referred to as "activation," based on the idea that the hemodynamic changes reflect underlying neural activation. The hemodynamic response function (HRF) has been carefully studied and characterized as a function with a delayed onset and a 10-12 sec evolution (Blamire et al., 1992). The hemodynamic response is known to vary considerably between individuals and between populations (e.g., young and old; Aguirre et al., 1998; D'Esposito et al., 1999). Thus, observations of age-related differences in the BOLD response could be due either to variability in the intrinsic hemodynamic response function (iHRF; that is subject-specific differences in the cerebrovascular reactivity that affects the BOLD response) or to bonafide age-related differences in neural activity. Thus, MRI signal-intensity change related to cognitive task performance may be most accurately thought of as an increase in neural activity convolved with the iHRF. That is, the convolution of neural activity with the subject-specific hemodynamic response. It is thus necessary to develop methods that can estimate, and account for, changes arising from the iHRF. Recent studies indicating that the HRF varies, not only between subjects but also between brain regions, suggest that we must consider not only subject-specific factors but also region-specific factors. Thus, Specific Aim 1 of our proposal is to develop and test a method for characterizing the intrinsic HRF (iHRF) by quantifying cerebrovascular reactivity in terms of separate vascular and neural delay components on a voxel-by-voxel basis. MRI technology has been applied to the study of neurocognitive aging in the hope that it may elucidate how the brain mediates age-related changes in cognitive-task performance. Results from these neuroimaging studies using functional MRI (fMRI) (and PET) have suggested important differences in the activation patterns of older and younger adults while they performed a variety of sensorimotor and cognitive tasks. These age-related activation differences are presumed to reflect fundamental differences in the cognitive mechanisms that younger and older adults utilize during task performance. The proposal would lead to insights regarding age- related cognitive performance changes through functional neuroimaging techniques which implies an assumption of age-equivalent cerebrovascular reactivity, i.e., the assumption of age-equivalent relationships between hemodynamic activity and neural activity on a voxel-by-voxel basis. The viability of the age-equivalent cerebrovascular reactivity assumption may be questioned on the basis of several lines of evidence that we will review below. In general, factors contributing to cerebrovascular reactivity are altered in older people. These age-related cerebrovascular changes could give rise to altered hemodynamic responses (Ito et al., 2002; Shah and Mooradian, 1997). We argue that, because the observed MRI signal is a result of both cerebrovascular reactivity and bonafide oxygenation changes due to neural activity, these two factors must be separated to gain a better understanding of observed age related changes in the MRI signal. Thus Specific Aim 2 of our proposal is to characterize age-related differences in the iHRF by quantifying age-related differences in cerebrovascular reactivity on a voxel-by-voxel basis. Pilot data collected from our site suggest the feasibility of estimating, on a voxel-by-voxel basis, the iHRF by deconvolving it into separate vascular delay and neural delay components. We propose that the variations in these two parameters result in regional and temporal differences between individuals (Biswal et al., 2003). We propose to first distinguish the relative effects of flow and oxygenation on the MR signal, and second, to generate new activation maps after accounting for each of these components. Thus Specific Aim 3 of our proposal is to develop studies to decipher the vascular and neural factors in older subjects and quantify the differences observed from each of the signal sources on a voxel-by-voxel basis. THE SPECIFIC AIMS OF THIS PROJECT ARE THE FOLLOWING: A.1. Estimating the iHRF. The hypothesis to be tested is that the iHRF can be modeled as a combination of neural (i.e., due to differences in onset of neural firing rates), vasomotor (due to flow changes during activation) and transit (due to differences in the red blood cell arrival time) delays. Although prior fMRI studies have reported variability in the observed temporal delays of up to several seconds among activated voxels, the precise source of the delay has not been well characterized. Further, significant temporal differences have 1 been reported in older subjects for identical task-activation paradigms. Dynamic susceptibility contrast fMRI will be used to develop a technique for decoupling the hemodynamic delay from the task-induced delay on a voxel- wise basis in healthy human volunteers. A.2. Characterization of age-related iHRF differences. The hypothesis to be tested is that aging induced changes in iHRF that occur due to the underlying vascular properties (i. e. vessel distribution, density etc.) are different in older subjects compared to young and can be quantified, fMRI data will be collected during different physiological challenges that increase blood flow and induce hemodynamic activity, independent of neural activity. These challenges include hypercapnia and breath hold, all of which lead to vasodilation, and consequently affect the MRI signal in the absence of a neural response. Results from this approach will permit better understanding of the biophysical mechanisms underlying the signal response and help us to reliably estimate age-induced iHRF changes. A.3. Consequences of iHRF estimation on task-induced age-related activation differences. The hypothesis to be tested is that accounting for age-related differences in the iHRF will lead to more accurate estimation of task induced activation than has been available before. Data will be collected from humans during performance of a working memory task that has been studied previously by our group using fMRI. Activation of young and old subjects will be observed during performance of a Digital Symbol Substitution task. Results from this approach will allow us to understand how accounting for age-related cerebrovascular reactivity (i.e. the iHRF) differences can permit more accurate measurement of neural activity on the basis of the BOLD hemodynamic response. 2